Structure-Function Studies of the Human Cytochrome P450 27 Family

Summary
The PI is requesting an administrative supplement to fund the purchase of an isothermal titration calorimeter
(ITC), specifically a Malvern MicroCal PEAQ ITC. The instrument will be used as a label-free approach to
measure binding constants (Kd or Ka) and thermodynamics (ΔH and ΔS) of enzyme-ligand interactions key to
experimental questions described in the parent award (1R35GM147276). This instrument will enable us to
perform more types of enzyme-ligand experiments than possible with our current equipment and to perform the
previously proposed experiments with greater confidence. All experiments are still in line with the original scope
of the parent award.

Public health relevance
This administrative supplement is to fund the purchase of an isothermal titration calorimeter (ITC) to measure the interaction strength of cytochrome P450 enzymes with other proteins or with small molecules. Interaction strength is key to understanding the role that these interactions play in how cytochrome P450 enzymes function and whether these interactions can be modified as a way to create new pharmaceutical therapies. The new instrument will allow more types of experiments to be performed than possible with our current equipment and the previously proposed experiments to be performed with greater confidence.